Shared Resource Management

SHARED RESOURCE MANAGEMENT (SRM): PROJECT SUMMARY
The goal of the Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) Shared Resources
Management (SRM) team is to ensure Center members have access to state-of-the-art technologies and quality
services to enhance high-impact cancer research and to promote dynamic scientific interaction and productivity.
Shared Resources (SRs) are overseen by Pierre-Alexandre Vidi, PhD, Associate Director (AD) of SR
Management (SRM). SRM’s Specific Aims are to: (1) Provide a unified management system to facilitate
operation and maintenance of state-of-the-art instrumentation, technologies, and quality services and to
maximize cost-effectiveness; (2) Coordinate the development of new services, the acquisition of equipment, and
phasing out of obsolete platforms and services, based on formal feedback mechanisms and strategic research
directions within the WFBCCC; (3) Promote intra- and inter-institutional collaboration of SRs to streamline project
pipelines and further expand services offered to WFBCCC investigators; and (4) Foster educational and training
initiatives of SRs through workshops, seminars, and courses. WFBCCC currently has nine SRs: Bioinformatics,
Biostatistics, Cell Engineering, Cancer Genomics, Crystallography and Computational Biosciences, Flow
Cytometry, Proteomics and Metabolomics, Qualitative and Patient Reported Outcomes, and Tumor Tissue and
Pathology. Two of these SRs (Qualitative and Patient-Reported Outcomes and Bioinformatics) were developed
over the project period and are fully operational. The SRs are managed by highly qualified Directors and
experienced staff. Reporting to the WFBCCC Director, Vidi oversees all SR operations and budget management.
There are two venues to support the management, planning, and evaluation of SRs. First, there is a Shared
Resource Advisory Committee (SRAC) for each SR. Each SRAC meets bi-annually and discusses the SR’s
scientific and financial performance, user fees, as well as needs for new services, and/or sunsetting obsolete
ones. Second, Vidi convenes an SR Oversight Committee, bringing together all SR Directors with the WFBCCC
Senior Leadership, to review and set overall policy for SR operations and to provide a forum for in-depth
discussions of the evolving research needs of WFBCCC investigators. SRs play a critical role in supporting the
WFBCCC Programs’ high-quality scientific research. During the current funding cycle, SRs provided a broad
range of services to all four WFBCCC Programs, directly contributing to research reported in over 450
publications and providing direct support services to 82% of the current WFBCCC members in support of their
cancer research.